SAFETY AND EFFICACY OF RHGH IN UNTREATED PATIENTS WITH GH DEFICIENCY

Recombinant human growth hormone is used in the treatment of growth hormone deficiency. Experimental variables have included dosage and frequency of administration. Outcome measures include somatic growth and attained height.